WaNPRC Macaca nemestrina SPF Breeding Colony

Project Summary/Abstract:
The goal of this project is to maintain and enhance the specific pathogen free (SPF) pigtail macaque (M.
nemestrina) breeding colony at the Washington National Primate Research Center (WaNPRC). This colony is
the largest domestic breeding colony of M. nemestrina and the primary source of this important animal model
for AIDS studies and other types of biomedical research in the United States. M. nemestrina have unique
immunological, genetic, behavioral, anatomical, and physiological characteristics that make them an essential
model in a number of areas of research related to HIV/AIDS. Specific pathogens (SIV, SRV, STLV-1, McHV-1)
are a threat to animal or human health or interfere with research and must be excluded to optimize nonhuman
primate research models. In this proposal, we discuss how we will maintain the WaNPRC SPF M. nemestrina
breeding colony to provide animals of the highest quality to meet research needs. We are in the process of
consolidating breeding operations at our Arizona breeding facility. Breeding and maintenance of the SPF
breeding colony, including financial sustainability, are described in Core 1, Husbandry and Management Core.
The viral testing that is performed to ensure that the colony remains SPF is described in Core 2, Viral Testing
Core. Genetic management and genotyping animals for parentage and major histocompatibility complex
alleles are described in Core 3, MHC Genetic Typing Core. The SPF M. nemestrina colony serves as a
national resource, providing animals to AIDS researchers across the country, with priority given to NIH-funded
investigators.

Public health relevance
Project Narrative: The pigtail macaque (Macaca nemestrina) is a critical resource for nonhuman primate models of human diseases, in particular for AIDS-related studies. The goal of this project is to increase the availability and improve the characterization of this resource to the research community.